Manipulating Epigenetic Control Mechanisms to Control HIV Transcription

DESCRIPTION (provided by applicant): Lifelong highly active antiretroviral therapy (HAART) not only presents formidable problems in terms of patient management, cost and long-term toxicities but also fails to eradicate the virus from infected individuals. HIV persists in the face of HAART due to constitutive low-level replication in sites that are poorly accessible to drugs and the development of latent infections in a variety of types including the long-lived memory CD4+ T cell population, macrophages, and microglial cells in the brain. The need to develop novel therapeutic tools to attack the latently infected population has been widely recognized, but there has been little progress using conventional drug development approaches. Here we propose to develop novel technologies allowing exploitation a natural epigenetic silencing mechanism, DNA methylation, to block HIV transcription. As a prelude to developing therapeutic silencing agents, a much better understanding of the natural silencing mechanisms used by cells to control retroviruses and retrotranspons is needed. Key questions about HIV silencing that remain to be answered include: What are the primary sequence triggers and mechanisms that induce silencing (i.e. protein repressors and/or viral-derived siRNA)? What conditions lead to proviral DNA methylation? Do similar silencing mechanisms operate in each of the cell types infected by HIV? Do drugs of abuse block HIV silencing by inducing histone acetylation? Therapeutic approaches to exploit silencing include development of small molecules that enhance DNA methylation, gene-specific induction of silencing by short double-stranded RNA (or it analogues) and silencing by direction of DNA methyltransferases to promoters through protein mediators. In contrast to traditional antivirals, which require continuous administration, therapeutic epigenetic gene silencing has the potential to produce stable inheritable blocks to viral replication after only a single exposure of an infec

Public health relevance
Most individuals treated with antiretroviral drugs have little to no detectable HIV in their circulation. However, this does not mean that the virus has been cleared from the body. In fact, a small number of cells persist where HIV has entered a state of dormancy, where the virus is invisible to the immune system and beyond the ability of current anti-HIV drugs to attack it. This latent HIV infection persists for the lifetime of the patient. Unfortunately, the virus can be readily induced and this leads to renewed active infections upon treatment interruption or failure. The need to develop novel therapeutic tools to attack the latently infected population has been widely recognized, but there has been little progress using conventional drug development approaches. Here we propose to develop novel technologies allowing exploitation of natural silencing mechanisms to irreversibly block HIV replication. The background to these studies is the observation that the establishment of HIV latency is an active process: specific chemical modifications of histones, normal cell proteins that bind to the DNA of genes and help regulate their function, inhibit HIV transcription. Unfortunately, stimulation of cells by certain immune hormones known as cytokines can reactivate HIV growth by reversing these chemical modifications. Fortunately, there are related modifications, including the methylation of DNA, that are essentially irreversible. In this proposal, we aim to study how HIV can be silenced in a variety of natural settings, how drugs of abuse can interfere with the silencing mechanisms, and how a natural silencing mechanism, DNA methylation, can be induced to ensure that latent HIV can no longer be reactivated. The great attraction of therapeutic gene silencing is it introduces a permanent and inheritable block to viral replication. In contrast to traditional antivirals, which require continuous administration, inducing a long-lasting cell-based suppression of viral gene expression can result, in theory, from a single exposure of an infected cell to a specific agent targeting the viral promoter.